Temporal dynamics of retinal ganglion cell neurodegeneration in glaucoma

? DESCRIPTION (provided by applicant): This research proposal seeks to improve understanding of the initial stages and longitudinal progression of glaucomatous neurodegeneration as a function of age. We will use our recently developed dual OCT- fluorescence imaging system to allow in vivo imaging of retinal ganglion cells (RGC). This system can image retinal anatomy with OCT and simultaneously image RGCs at the cellular level with confocal-gated fluorescence microscopy. Imaging is complete within seconds without the need to serially switch to a different machine or modality. To our knowledge, this is the first system with this integrated, simultaneous capability. Consequently, repetitive longitudinal imaging of the same animal and its retinal changes is possible. Utilizing a novel genetic mouse model of normal pressure glaucoma that we recently generated, we will determine the temporal profile and dynamics of glaucomatous RGC neurodegeneration over 12 months. This research has direct clinical applicability by providing critical data on glaucoma pathophysiology and powerful new tools to the glaucoma research community.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to public health because it is expected to improve understanding of glaucoma pathophysiology - one of the leading causes of blindness worldwide. By using innovative imaging techniques and novel mouse models of glaucoma that our laboratories recently developed, we expect to improve our understanding of early glaucoma disease mechanisms and neurodegeneration with increasing age. This provides the potential to improve early diagnosis of glaucoma before visual impairment and blindness occur and could lead to new therapies.